Administrative and Research Translation Core

Administrative & Research Translation Core ABSTRACT
The Administrative and Research Translation Core is the central hub for all activities of the Texas A&M University
Superfund Research Center. It is organized around three key functions that will enable it to be an effective and
nimble coordinator of the proposed research, outreach, training, and translation activities: (1) administration and
fiscal management, (2) integration of cross-disciplinary disaster response research (DR2), and (3) outreach and
research translation. This Core is physically located in the Department of Veterinary Integrative Biosciences at
Texas A&M University in College Station, TX. The Core operates through regular Center-wide and project-
specific meetings, tracks the productivity of the Center, develops future activities, and guides scientific innovation
through a pilot project program. The Core is led by Center Director (Ivan Rusyn) and Associate Director
(Weihsueh Chiu), and includes an administrative manager and a fiscal manager. The Core is coordinating Center
leadership and activities with two committees. The PIs of the projects and cores in the Center form a Scientific
Steering Committee, which meets monthly. External oversight of the Center is the responsibility of an External
Advisory Committee, which meets annually to perform program evaluation of the Center and determine whether
research, outreach, training, and translation goals and objectives are being met. This Committee is a diverse
group of highly qualified experts representing academia, federal and state governmental agencies, industry, and
non-governmental organizations. The Core’s work is organized around five Specific Aims. First, the Core
provides effective administrative and fiscal management with input from the Scientific Steering and External
Advisory Committees. The Core conducts program planning and evaluation and assessment of Center
performance. Second, the Core enables integration of cross-disciplinary DR2 research through monthly
meetings, annual retreats, and internal/external collaborations. The Core issues annual calls for pilot projects,
coordinates their review and oversees deliverables from each pilot project. Third, the Core promotes
dissemination of the Center’s outputs to NIEHS and other stakeholders. Fourth, the Core maintains and expands
partnerships with government (local/state/Federal) agencies, non-governmental organizations (NGOs) and
community partners. It will continue holding regular meetings with the end-users to showcase Center’s work and
conduct demonstration workshops. Finally, the Core is advancing the practical application of Center DR2
research through technology transfer. All Center faculty, staff and trainees will interact with the Core as it
executes its administrative (overall and fiscal management, integration) and research translation
(communication, outreach, technology transfer) functions.

Public health relevance
Administrative & Research Translation Core NARRATIVE The Administrative & Research Translation Core is providing leadership and guidance to the Texas A&M University Superfund Research Center. It provides general Center malmanagement support, promotes cross- discipline interactions among all projects and cores, and facilitates research translation. The Core operates through regular Center-wide and project-specific meetings, tracks the productivity of the Center, develops future activities, and guides scientific innovation through a pilot project program. The Core also coordinates the Center’s disaster research response (DR2) activities, training, community engagement and outreach with input from two advisory committees.